Role of APOE in endosomal processing of alpha-synuclein

Role of APOE in endosomal processing of alpha-synuclein
Dementia is among the most harmful and costly aspects of Lewy body disease (LBD) which is comprised of
Parkinson disease (PD) and dementia with Lewy bodies (DLB) and shares some clinical features with
Alzheimer’s disease. In particular, dementia and psychosis are often early and aggressive symptoms in
patients with DLB. Pathologically, these illnesses share the feature of aggregation of misfolded forms of the
protein alpha-synuclein (aSyn), termed Lewy bodies, which spread throughout multiple brain regions during
the disease and are toxic to cells. In addition to Lewy bodies, patients with LBD often have amyloid plaques
and neurofibrillary tangles which are hallmarks of Alzheimer’s disease, and patients with Alzheimer’s disease
often have Lewy bodies in addition to plaques and tangles. The exact mechanism of how aSyn becomes
misfolded and why cognitive decline is accelerated in DLB is unclear. Genetic studies point to a strong link
between increased DLB risk and the APOE4 variant of the gene that encodes apolipoprotein E, another protein
that is also central to Alzheimer’s disease risk. We reported that mice expressing the APOE4 version of the
human APOE gene had accelerated aSyn aggregation and early death compared to other APOE genotypes.
This finding is similar to the effects observed when human APOE genotypes are expressed in mouse models
of Alzheimer’s disease. Our preliminary data indicate that astrocytes and microglia take up aSyn aggregates
and process them through the endolysosomal pathway, which may serve as a compensatory mechanism to
degrade harmful aSyn aggregates. We propose to examine the cell biological transit of aSyn aggregates
through the endolysosomal pathway in astrocytes and microglia and determine if there are differences in this
trafficking related to APOE genotype. We hypothesize that the APOE4 genotype impairs endolysosomal
degradation of aSyn aggregates in both astrocytes and microglia, and that astrocyte expression of APOE4 in
particular drives accelerated aSyn pathology leading to brain dysfunction and neurodegeneration. We will test
whether this effect occurs mainly due to cell-autonomous changes within astrocytes or microglia themselves,
including related to changes in gene expression in those cells, or whether it is mediated through secreted
apolipoprotein E protein particles that are known to have effects by binding to receptors on both neurons and
glia. The main goal of these experiments is to clarify how APOE genotype regulates endolysosomal processing
of aSyn in astrocytes and microglia and how this knowledge can be leveraged to develop novel treatments for
DLB, Alzheimer’s disease, and other related dementias.

Public health relevance
Dementia with Lewy bodies (DLB) causes a pattern of symptoms that overlaps with symptoms observed in patients with Parkinson’s disease and Alzheimer’s disease. Patient with DLB have accelerated cognitive impairment and psychosis compared to patients with Parkinson’s disease, and at autopsy they frequently have features that are found in the brains of patients with Alzheimer’s disease, including amyloid plaques and neurofibrillary tangles, in addition to the hallmark Lewy bodies that are composed of the protein alpha- synuclein (aSyn). The factors that cause patients with DLB to develop dementia more rapidly than patients with Parkinson’s disease are not completely understood, but the APOE4 variant of the apolipoprotein E gene is strongly associated with risk of DLB, similar to its association with risk of Alzheimer’s disease. We recently reported that human forms of APOE specifically regulate pathological aggregation of aSyn when expressed in mice. We will investigate the relationship between APOE genotype and specific cell types that accumulate aSyn aggregates which are believed to contribute to neurodegeneration in DLB. Specifically, we will examine the impact of APOE genotype on the ability of astrocytes and microglia, two important types of glial cells in the brain, to take up and degrade harmful aSyn aggregates. By better understanding the genetic and cellular changes that link the APOE4 risk gene to pathological aSyn aggregation and neurodegeneration, we should be able to develop novel treatments to slow and prevent DLB, Alzheimer’s disease, and related dementia illnesses.